Development of B-cell-based vaccine for Glioblastoma

PROJECT SUMMARY/ABSTRACT
Immunotherapy has revolutionized the treatment of many tumors. However, most GBM patients
have not, so far, benefited from immunotherapeutic treatment. With the goal of exploring ways to
boost anti-GBM immunity, we've developed a B-cell-based vaccine (BVax) that consists of 4-1BBL+
B cells activated with CD40 agonism, BAFF and IFNγ stimulation. BVax migrate to key secondary
lymphoid organs and are proficient at antigen cross-presentation, which promotes both the
survival and functionality of CD8+ T cells. A combination of radiation, BVax, and PD-L1 blockade
conferred tumor eradication in 80% of treated tumor-bearing animals. This research proposal
aims to understand the immune mechanisms underlying this protection and prevention of tumor
growth. We will focus on two processes: generation of CD8+ T-cell memory formation (Aim 1) and
Ab production (Aim 2). We hypothesize that both effector functions elicit protective anti-GBM
immunity.
We have been successful at generating GBM patient-derived BVax that activated autologous CD8+
T cells, which shows a strong ability to kill autologous glioma cells. This demonstrates that BVax
can be produced from patient's peripheral blood. We now aim to further characterize and optimize
BVax treatment protocol to inform future clinical application of this therapeutic approach (Aim 3).
Overall, our study provides a novel alternative to current immunotherapeutic approaches that can
be readily translated to the clinic.

Public health relevance
PROJECT NARRATIVE Immunotherapy is a promising approach to treat glioblastoma patients, yet its efficacy so far has been very limited. Our work provides an opportunity to explore the B-cell-based vaccine as immunotherapy to treat deadly tumors, including glioblastoma. Our approach utilizes 4-1BBL+ B cells as a cellular platform to promote anti-tumor immunity.